2023 Cell Contact and Adhesion Gordon Research Conference and Gordon Research Seminar

Project Summary
This application requests funds to support the 2023 Gordon Research Conference on Cell Contact & Adhesion
on June 25-June 30, 2023 and its associated Gordon Research Seminar for undergraduates, graduate
students, and postdoctoral fellows from June 24-25, both at Colby Sawyer College in New London, NH. The
goal of this meeting is to catalyze durable collaborative relationships among basic scientists and
cancer researchers that will uncover novel insight into the molecular mechanisms underlying tumor
cell invasion and metastasis. To achieve this goal, the organizing committee has recruited speakers who
are international leaders who seek to understand cell-cell adhesion in development and cancer. The speakers
use a variety of techniques, model systems, and investigate different cancer subtypes. Additionally, the list of
speakers includes the leaders in the field as well as “up-and-coming” new investigators. Currently, the
program consists of 25 speakers, including 12 women (48%) and two under-represented scientists. Seven
invited speakers are junior faculty (29%), and nine come from institutions outside the USA (36%). Key in
fostering interactions at this conference is: (1) a total immersion experience in which scientists of all levels not
only attend scientific discussions together, but also reside and socialize with one another, and (2) the
incorporation of a Gordon Research Seminar prior to the conference in which junior scientists assemble as a
group and listen and discussion research presentations by their peers.

Public health relevance
Narrative This application requests funds to support the 2023 Gordon Research Conference on Cell Contact & Adhesion on June 25-June 30, 2023 and its associated Gordon Research Seminar for undergraduates, graduate students, and postdoctoral fellows from June 24-25, both at Colby Sawyer College in New London, NH. The goal of this meeting is to catalyze durable collaborative relationships among basic scientists and cancer researchers that will uncover novel insight into the molecular mechanisms underlying tumor cell invasion and metastasis. The insight gained from this conference will cause investigators to embark into new areas and forge new collaborations. The ultimate consequence will be a greater potential to make scientific breakthroughs that ultimately could improve the lives of cancer patients.